ANALYSIS OF SYNOVIAL FLUID FROM SHOULDER JOINTS FOR MARKERS OF OSTEOARTHRITIS

This project will investigate the clinical staging of patients undergoing surgical treatment of shoulders with glenohumeral osteoarthritis, and relate this to synovial fluid levels of biochemical markers of cartilage metabolism.